The Texas Resource Center on Minority Aging Research (RCMAR)

This is an application to renew the Texas RCMAR, initially funded in 2018 based at the University of Texas Medical Branch (UTMB) in Galveston with the University of Texas at Austin (UT-Austin) as a collaborating institution. A major innovation of the proposed RCMAR’s second cycle is that we will use a Multiple PI arrangement, and partner with the University of Texas at San Antonio (UTSA). We propose to maintain the organizational structure of two Cores: Leadership and Administration (LAC) and Analysis Core (AnC), in addition to the Research Education Component (REC). The overall RCMAR leaders serve as leaders of the LAC as well. The other components have leaders from both UTMB and UTSA. UT-Austin will remain an affiliated institution, contributing in particular with REC activities for networking and program dissemination. The Aims of the Texas RCMAR overall, as described in the three components are: Create the infrastructure to support rigorous research in behavioral and social research on aging and health of older adults; Support the AnC and REC in their mentoring, education, and research activities; Evaluate Center progress toward continuous improvement; Provide measurement, statistical, and methodological support for pilot research projects; Collect, disseminate, maintain, and update infrastructure on sources of data relevant to aging research, and measurements of social determinants of health to all Texas RCMAR investigators and Scientists; Develop, present, and disseminate instruction in advanced analytical methods for our Scientists and other affiliates; Identify, recruit, and retain RCMAR Scientists, qualified candidates who have the potential to develop successful careers in aging research and health consistent with the mission and theme of the Texas RCMAR; Create and monitor an Individualized Career Development Plan for each Scientist; and Implement and monitor a Structured Program of Mentoring and Research Education, with activities targeted for the scientists in the program. We have assembled a group of multidisciplinary faculty who will form the Mentoring teams of the RCMAR Scientists, representing social and behavioral sciences as well as epidemiological and biomedical sciences. We will leverage our existing resources from P30’s, K12, KL2, and individual R01’s to support the program of activities. The Texas RCMAR theme of migration, aging, and health draws on multidisciplinary strengths, and the combined expertise of the RCMAR participating faculty in large population-based longitudinal studies that support aging research, and a goal to incorporate in-depth measures and approaches to contribute to aging research and health. UTMB and UTSA have a long tradition of training scholars on aging research and will now collaborate to expand the impact and reach of the Texas RCMAR.

Public health relevance
The overall purpose of the Texas RCMAR is to enhance the aging research workforce by mentoring early-carrier scientists focused on behavioral, social, and medical research related to populations in Texas, the Southwestern United States, and Mexico. . Through our Leadership and Administrative Core (LAC), Analysis Core (AnC) and Research Education Component (REC), we will continue to leverage our national and international network of colleagues to develop infrastructure to promote advances in these areas and to increase the number of investigators in the area of health and aging research. Our success in mentoring RCMAR Scientists into independent researchers will expand, with the addition of the University of Texas at San Antonio as a new partner, joining the University of Texas Medical Branch and the University of Texas at Austin in support of our theme of Migration, Aging, and Health.